Effect of Ubiquitin D variants upon APOL1-mediated kidney injury

PROJECT SUMMARY
Despite the success of antiretroviral therapy in improving mortality, persons with HIV (PWH) have shortened
lifespan and increased prevalence of non-infectious diseases including chronic kidney disease (CKD). HIV-
associated nephropathy (HIVAN) occurs almost exclusively in persons of African ancestry and variants of the
APOL1 gene, which confer resistance to trypanosomal disease, markedly increase risk of progressive CKD.
14% of African Americans have APOL1 high risk (HR) genotypes, which confer a 29-89-fold increased risk of
HIVAN among PWH, likely by predisposing glomerular podocytes to HIV-induced injury. Since most persons
with APOL1 HR genotypes never develop kidney disease, additional “hits”, including viral infection (HIV,
SARS-coV-2), exposure to high levels of interferon, and/or additional genetic factors, are necessary to initiate
progressive CKD. Our group was the first to identify a role for the ubiquitin-like protein Ubiquitin D (UBD) in the
pathogenesis of kidney disease (HIVAN). We reported roles for UBD in promoting HIV-induced kidney
epithelial cell injury and innate immune activation. A role for UBD in modulating kidney injury in APOL1-
mediated kidney disease is supported by recently published studies demonstrating increased UBD expression
in glomeruli in humans and mice with APOL1 HR genotypes and kidney disease and a recent report that UBD
increases APOL1 degradation in vitro. Our analysis of the UBD gene locus identified a haplotype comprised of
four missense mutations with an allele frequency of 0.43 in African Americans but only 0.02 in Europeans. Our
preliminary data demonstrate that this haplotype (UBDb) is associated with a 5.8-fold increased risk of HIVAN
in persons with APOL1 HR genotypes. Further, data from our laboratory indicate that there are important
functional differences in the UBDb protein compared to UBDa (reference allele). However, the mechanism by
which the UBDb variant synergizes with APOL1 risk alleles to promote kidney injury is unknown. Since UBD
can covalently and non-covalently interact with cellular proteins and increase/decrease degradation or alter
protein function, we will test our hypothesis that the UBDb variant increases the risk of HIVAN via changes in
interactions with APOL1 and other proteins, leading to podocyte injury. We will test our hypothesis and address
critically important questions in two Specific Aims. In Aim 1, we will determine the effects of the UBDa and
UBDb alleles upon HIV-induced injury and inflammatory responses in novel human podocyte lines with APOL1
HR and non-risk genotypes. In Aim 2, we will use high throughput proteomics and targeted in vitro assays to
delineate differences in covalent and non-covalent protein-protein interactions of UBD variants and effects of
UBD variants on APOL1 protein ubiquitination and degradation in human podocytes with APOL1 HR and non-
risk genotypes. These innovative and important studies will delineate novel mechanisms underlying the
increased risk of CKD in PWH, allowing us to devise new strategies to prevent and treat CKD this population.

Public health relevance
People with HIV are at increased risk of chronic kidney disease, which is mediated in part by genetic variants in the gene APOL1. We have identified a novel genetic variant of Ubiquitin D, which increases APOL1-mediated kidney injury. We therefore will perform innovative studies using novel human kidney cell models to determine how Ubiquitin D variants increase APOL1 toxicity, with the goal of improving the care of people with HIV.